Chemokine Receptor Antagonists (CRAs): Characterization in Preclinical Models of Methamphetamine Use Disorder

Methamphetamine (METH) addiction lacks an approved medication, which is different from opioid, alcohol and
nicotine addiction. The NIDA therapeutic pipeline for psychostimulant addiction is also limited compared to
opioid use disorder. This indicates a need to identify new targets and strategies for METH use disorder (MUD).
The neuroimmune system is one promising target. It sits at the crossroads of the immune and central nervous
systems. Neuroimmune signaling in brain circuits related to addiction is dysregulated during METH exposure
and abstinence, and this dysregulation facilitates METH dependence and relapse. Non-selective anti-
inflammatory agents are effective in animal models of psychostimulant addiction but can disrupt normal
immune function. We propose a more selective strategy, one which targets a specific element of the
neuroimmune system. The element we selected is the chemokine system, namely a trio of chemokine
receptors (CCR2, CCR5 and CXCR4) that are (1) expressed in brain circuits that underlie METH dependence
and relapse; (2) dysregulated during METH exposure; (3) enhance multiple neurochemical correlates of METH
addiction (e.g., dopamine and glutamate transmission); and (4) `druggable' receptors with FDA-approved
antagonists and a mechanistically unique preclinical antagonist. The overall hypothesis to be tested is that
chemokine receptor antagonists (CRAs) blocking three different chemokine receptors (CXCR4, CCR2, and
CCR5) will reduce METH intake, reinforcing efficacy, and relapse in SA assays, counteract anxiety-like effects
during METH withdrawal, and normalize dysregulation of chemokine-dopamine crosstalk after chronic METH
intake. The CRAs proposed for characterization are not known to be abuse liable, mechanistically distinct, and
positioned at different stages of the neuroimmune pipeline. Two of the CRAs (AMD3100, a CXCR4 antagonist
and maraviroc, a CCR5 antagonist) are approved for other therapeutic indications and eligible for repurposing.
R-103, a preclinical CRA, is mechanistically unique because it blocks multiple chemokine receptors (i.e.,
CCR2, CCR5, CXCR4), thus offering potential for enhanced efficacy. R-103 also has favorable safety and
pharmacokinetic profiles, including rapid brain entry and persistent brain and plasma levels. Since the CRAs
proposed for testing may have varying potencies, half-lives, and metabolic/PK parameters, we will also
determine the causal role of the specific chemokine receptors in METH intake and relapse behaviors using
shRNA knockdown of CCR2, CCR5 and CXCR4 in the mesolimbic pathway. In summary, our results will offer
the first comprehensive information about the efficacy of CRAs and the influence of specific chemokine
receptors on METH SA behaviors and neurochemical effects. By identifying the most effective CRA, and
determining the chemokine receptor with the greatest influence, we expect to pave the way for developing
effective chemokine-based medications for METH use disorder.

Public health relevance
PROJECT NARRATIVE Chemokine receptors in brain reward pathways are upregulated during methamphetamine exposure and interact with dopamine and glutamate systems that contribute to methamphetamine use disorder . By providing the first comprehensive in vivo study of mechanistically distinct chemokine receptor antagonists (CRAs) in animal models of methamphetamine addiction, we expect to provide an initial step in identifying CRAs as neuroimmune-based, non-addictive therapeutics for substance use disorders.